Functional relevance of C. trachomatis trp operon polymorphism

PROJECT SUMMARY
The trp operon in several bacterial species is regulated at multiple levels that include transcription, translation,
post-translation, and enzyme activity. The recent discovery of a distinct attenuation mechanism of C. trachomatis
trp operon, which we termed “trans”-attenuation because it involved a trans-acting factor, the tryptophan-
biosensing YtgR repressor, points to the significance of maintaining stringent regulation of expression of the
tryptophan salvage genes. Regulation of trp operon by the TrpR repressor and attenuator is thought to be a
check on the relatively high metabolic cost of tryptophan biosynthesis, with transcription only induced when
tryptophan levels are low. The biosynthesis of tryptophan is an energetically costly process due to its requirement
for D-erythrose-4-phosphate, phosphoenolpyruvate and ATP for chorismate biosynthesis, as well as glutamine,
phosphoribosyl pyrophosphate and serine for the conversion of chorismate to tryptophan. It is not clear if this
applies to C. trachomatis, which only requires one step – serine and indole condensation reaction to form
tryptophan. Instead, we propose an alternative model, whereby dysregulated transcription of the tryptophan
synthase genes trpB and trpA leads to serine overutilization, diverting this amino acid away from other serine-
requiring metabolic pathways, such as phosphatidylserine (PS) biosynthesis. The additional YtgR-mediated
regulation of trpBA expression ensures equitable distribution of serine between tryptophan and PS production.
The iron-dependent regulation by YtgR is also proposed to be essential for optimal expression of trpBA in
tissue environment that support indole-producing microbiome, such as the stratified squamous epithelium of the
female lower genital tract. During epithelial cell differentiation, the gene for transferrin receptor, TFRC is
progressively downregulated. We previously reported that the slow transferrin receptor recycling pathway is how
C. trachomatis acquires iron. Therefore, TFRC downregulation would subject the pathogen to gradual iron
starvation. Noteworthy is the location of the microbiome to the uppermost differentiated layers of the squamous
epithelium; and YtgR through its iron-responsiveness could be how Chlamydia senses its proximity to indole-
producing microbiota. We propose that this underpins YtgR/IGR importance to C. trachomatis.
The trans-attenuation function of YtgR on the trp operon relies on a triple tryptophan motif (WWW) that
renders translation of the precursor protein YtgCR sensitive to tryptophan-limiting growth conditions. We
obtained evidence that there are several genes that are transcriptionally induced when tryptophan is at low
levels, but are not regulated by the tryptophan-responsive TrpR repressor. Therefore, there must be another
transcriptional regulator responsible. We propose that YtgR fulfills this role, which would mean a more global
role for this repressor in regulating transcriptional adaptation strategies in times of tryptophan limitation.

Public health relevance
PROJECT NARRATIVE (Relevance) Chlamydia trachomatis is a medically relevant pathogen that depends on host for its nutritional requirements, thus placing the pathogen in a metabolic situation that demands balanced utilization of nutrient resources. Here, we investigate how the unusual means of regulating the trp operon accomplishes this balancing act to ensure that a specific substrate is available to the other metabolic pathways that requires it. Investigations will revolve around the intergenic region of the trp operon, which was previously characterized to mediate regulation by the transcriptional repressor YtgR.